Neural mechanisms of sound activation of vestibular system

DESCRIPTION (provided by applicant): The overall objective of the application is to provide the neural basis for human VEMP testing (vestibular evoked myogenic potentials) by rigorously examining vestibular afferent responses to clinical VEMP stimuli. Since the discovery of cervical neck muscle myogenic potentials in 1992, there has been a rapid growth of VEMP publications and clinical use. Investigators worldwide have used the VEMPs to characterize vestibular deficiencies related to aging and a variety of peripheral and central vestibulopathies, including Tullio/superior canal dehiscence syndrome, vestibular neuritis, Meniere's disease and tumors. The application is motivated by two basic facts. First, there is a need of rigorous animal basic science research on the neural basis for VEMP testing. Second, our studies clearly demonstrated that the canal as well as otolith afferents responded to VEMP stimuli. Since neck muscles receive inputs from both the canals and the otoliths, our results cast doubt on the current interpretation of VEMP testing, and call into question which vestibular organs are responsible for VEMP responses under various experimental and clinical conditions-knowledge important for clinical design of discriminating VEMP tests and interpretation of clinical results. In the application, we will examine single unit vestibular afferent responses from identified organs to air-conducted (Aim 1) and bone-conducted sound stimuli (Aim 2) that are used clinically. We will determine if certain sound stimuli preferentially activate specific vestibular end organs. Our preliminary results support this idea and have shown that sound stimuli with certain intensity and frequency preferentially activate the otoliths vs. the canals. The results from the proposed experiments would lead to optimal VEMP testing protocols and interpretive guidelines. The basis of the organ selectivity is hypothesized to be biomechanical- i.e., related to how acoustic energy is transmitted through the labyrinth. We will examine the hypothesis by constructing a 3D biomechanical model of sound activation of the vestibular end organs.

Public health relevance
Sound-evoked vestibular myogenic potentials (VEMPs) are becoming a common clinical test of vestibular function, yet we really do not know how the vestibular organs are activated by sound. The knowledge obtained from the study will contribute to understanding sound activation of vestibular end organs and provide insights into developing and interpreting human VEMP tests.